Mechanisms of signal transmission in vertebrate skin appendage development.

PROJECT SUMMARY/ABSTRACT
Skin appendages, including teeth, hair, eccrine and mammary glands, are conspicuous and medically impor-
tant features of the human integument. Congenital and acquired disorders of skin appendages are common
and frequently debilitating conditions. Although human genetic analyses and clinical dermatology have associ-
ated numerous loci with skin appendage disorders, the molecular etiologies linking genetic lesions to human
phenotypes in many cases remain obscure. Understanding molecular mechanisms that regulate skin ap-
pendage patterning and morphogenesis in experimental model systems provides new avenues for developing
therapies for skin disease. Indeed, research on chicken and mouse model systems has greatly advanced our
understanding of the genetic regulation of skin appendage development and has already impacted clinical
dermatology. Importantly, patterning cues, morphogenetic cell behaviors and the regulatory mechanisms that
link them are conserved in zebraﬁsh skin appendage development. Because skin appendages form superﬁcial-
ly in the transparent skin of developing ﬁsh, studying zebraﬁsh skin patterning and morphogenesis enables in
vivo analysis of cellular and molecular dynamics at resolutions not currently possible in other model systems.
Studies in Aim 1 will contribute to our understanding of how the correct distribution of skin appendages is
achieved by leveraging live imaging and conditional genetics to test the role of a novel population of migratory
dermal cells likely to regulate skin appendage patterning. These studies will also uncover, for the ﬁrst time,
molecular mechanisms that govern dermal cell migration in intact vertebrate skin. Studies in Aim 2 will eluci-
date mechanisms regulating the dynamic spatial distribution of signaling proteins known to be necessary for
epithelial–mesenchymal interactions during early skin appendage morphogenesis in humans. By using condi-
tional transgene expression to re-construct signaling networks in a zebraﬁsh model of hereditary ectodermal
dysplasia, these experiments will reveal mechanisms governing epithelial–mesenchymal signaling interactions
at molecular resolution. Together, these studies will address some of the most important unanswered questions
regarding skin appendage development and provide potential inroads to understanding the molecular etiology
of human disorders affecting these tissues.
1

Public health relevance
PROJECT NARRATIVE Defective patterning and morphogenesis of human skin appendages—including hair and skin glands—leads to common heritable and acquired disorders that have profound effects on health and well-being of affected indi- viduals. This project introduces a novel and unusually accessible system, skin development in zebraﬁsh, for elucidating the molecular cues and fundamental cell behaviors that drive early stages of skin appendage mor- phogenesis and govern their spatial distribution in the skin. By imaging live dermal cells in intact animals while manipulating functions of biomedically relevant gene products, this work will provide novel insights into the fundamental biology of the skin and open new avenues for elucidating etiologies of hereditary and acquired skin appendage disorders. 1